Development of a rapid screening test for the detection of dihydroanatoxin-a

Project Summary
Dihydroanatoxin (dhATX) derived from cyanobacteria is a rapidly emerging global problem that negatively
impacts human and animal health. Poisoning induced by dhATX is characterized by a broad array of neurological
and cardiovascular symptoms with extremes of severity which can lead to fatality. Therefore, efficient, and
effective detection, prevention, control, and mitigation technologies are critically needed to prevent exposures.
The only available technology to detect the presence of dhATX is expensive, time consuming, and labor
intensive, allowing only sporadic testing to be performed. This lack of rapid, simple, inexpensive testing capability
increases the chances of human and animal exposures and associated health problems. Based on our current
progress in developing rapid assays for environmental toxins, we will develop a rapid, quantitative, and cost-
effective receptor binding assay for detecting dhATX in the field setting. Our test platform will likely emerge as
an integral component of monitoring programs domestically and internationally to improve dhATX detection, and
will provide an effective tool for public health officials to act quickly to reduce dhATX exposures.

Public health relevance
Project Narrative Dihydroanatoxin-a (dhATX) is a potent neurotoxin belonging to the anatoxin-a family of cyanotoxins, which impacts both the environment and human/animal health. Efficient and rapid detection of dhATX is key to mitigating its effects; however, the only available method to test for the presence of dhATX derived from toxin-producing cyanobacteria is labor intensive, time consuming, costly, and complicated, requiring highly specialized labs. We will develop a rapid, inexpensive, and simple to use device for detecting dhATX in the field. Our assay will improve screening and detection workflow leading to enhanced mitigation of dhATX in food and water sources.